Arm Motor Rehabilitation, Entertainment and Cognition System for the Elderly

PROJECT SUMMARY OBJECTIVES 795,000 Americans experience a CVA yearly. More intensive rehabilitation early sub-acute post-CVA was found to produce better recovery. The first objective is the development of a relatively low- cost medical device with small clinical footprint. The BrightArm C (BAC) is a compact robotic table with bimanual hand controllers that track full 3D arm movement, measure finger grasp and extension, arm pronation/supination, and monitor health through biosensors. UE movements will be induced during interaction with virtual games. The second objective is to determine the efficacy of BAC for the in-patient and outpatient therapy continuum compared to standard of care. We expect that the new integrative therapy, when added to conventional rehabilitation will result in higher functioning individuals for the same time period. SPECIFIC AIMS 1) Develop the BrightArm C robotic table with novel UE controllers and custom integrative games. Conduct a usability and a feasibility study with Roosevelt Care Center on inpatients sub-acute post- CVA. 2) Longitudinal randomized clinical study of 24 subjects sub-acute post-CVA, inpatients and then outpatients at Kessler Institute for Rehabilitation. Enroll 24 caregivers and obtain their periodic feedback. METHODS 1) Complete mechanical and electronic design of the robotic table, construct a prototype, preform operational testing and validate UE tracking over the entire table. 2) Design and fabricate forearm controllers measuring grasp strength and finger extension, forearm pronation/supination and integrated biosensors. Develop arm position modeling and conduct reliability testing. 3) Interface UE movements captured by hand controllers with an enhanced game library. Integrative games will train motor function and cognitive domains of executive function, memory, focusing and language comprehension. 4) Conduct a usability evaluation on elderly volunteers. 5) Conduct a feasibility study with 6 inpatients early sub-acute post-CVA, showing good technology acceptance and clinical benefit. 6) Build and deploy two BrightArm C systems at Kessler Institute for Rehabilitation, one for subjects in the sub-acute phase post-CVA training 2-3 weeks inpatient and one for outpatients training 2-3 months (2-3x/week). 7) Compare outcomes of experimental (n=16) and control groups (n=8), both undergoing standardized evaluations in the motor, cognitive and quality of life domains. Evaluate pre-/post-inpatient and pre-/post/follow-up -outpatient therapy. Success means better outcomes for experimental group, with an average of 5 points larger increase in Fugl-Mayer assessment, average 6 point more in CAHAI-9, larger increase in executive function, memory, and a 5 point larger reduction in depression. Periodically collect caregiver feedback to determine generalization to independence in real-life activities. NIH RELEVANCE: Nationwide annual costs of CVAs are expected to grow to $240 billion by 2030. This project will reduce these costs by improving ADL function, cognition and quality of life through early, intensive intervention post-CVA. Individuals post TBI, cerebral palsy, or post shoulder surgery may also benefit.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: 795,000 Americans experience a CVA yearly [CDC 2015], and more intensive rehabilitation in the sub-acute (early) phase was found to produce better recovery [Chen et al 2002]. A compact robotic table that uses bimanual therapeutic VR games to induce a high number of active arm repetitions, improve finger grasp and extension, promote forearm pronation/supination, adapt to motor and cognitive impairments, and track performance for clinicians will benefit multiple patient populations (those post CVA, traumatic brain injury, cerebral palsy, and post-shoulder surgery). The BCI system facilitates a continuity of sub-acute care from inpatient to outpatient, while reducing health care costs through integrative rehabilitation.